A Two-Tier Effect-Based Water Bioactivity Surveillance System.

Title: A Two-Tier Effect-Based Water Bioactivity Surveillance System.
ABSTRACT. Chemical polluƟon of water threatens public health worldwide, linked to ~1.4 million
deaths/year. Man-made chemicals have surged from ~1,000 in 1900 to over 350,000 today, with annual
producƟon exceeding 1,000 million metric tons. Many remain untested, complicaƟng water safety
oversight. ConvenƟonal water tesƟng focuses on a few known contaminants, lacks biological context,
and fails to capture the synergisƟc effects of complex mixtures. To address these gaps, we propose a
two-Ɵer approach—WASANET—built on Attagene’s FACTORIAL platiorm. The FACTORIAL assay
quanƟtaƟvely measures mulƟple transcripƟon factor (TF) acƟviƟes, generaƟng an Aggregate Response
Index (ARI) that reflects overall bioacƟvity of water samples. Validated under the U.S. EPA ToxCast
program and recognized by a White House Tibbetts Award, this platiorm provides a uniform scale for
comparing diverse water sources. Tier I emphasizes rapid, cost-effecƟve triage screening to idenƟfy “hot
spots” via a high-throughput FACTORIAL ARI assay, enhanced with key xenobioƟc-metabolizing enzymes
for broader detecƟon. Tier II combines targeted chemical analyses with the FACTORIAL assay to pinpoint
the specific contaminants driving observed bioacƟvity, enabling more effecƟve remediaƟon strategies.
SPECIFIC AIM 1: Build the infrastructure for Tier I water safety surveillance.
1A. Develop a single-step, high-throughput FACTORIAL ARI assay.
1B. Enhance metabolic capabiliƟes using criƟcal metabolic enzymes.
1C. Establish standardized workflows for sample handling and data management.
SPECIFIC AIM 2: Develop Tier II methodology to idenƟfy the most impactiul pollutants.
2A. Integrate the FACTORIAL assay with chemical analyses to locate criƟcal contaminants.
2B. Validate Tier II using samples with known pollutant profiles.
SPECIFIC AIM 3: Deploy a prototype WASANET system in collaboraƟon with water authoriƟes and
researchers in CA, NC, and IA, evaluaƟng both environmental and residenƟal sources.
By delivering quanƟtaƟve ARI scores, WASANET permits clear risk comparisons across sites and helps
prioriƟze hotspots for in-depth invesƟgaƟon. IdenƟfying key toxicants further supports cost-effecƟve
remediaƟon and targeted regulatory measures.
This high-content strategy bridges criƟcal gaps in convenƟonal water tesƟng, providing acƟonable data
on both known and hidden hazards. The proposed work will demonstrate WASANET’s feasibility, setting
a foundaƟon for widespread adopƟon and improved public health protecƟon. Overall, WASANET offers a
transformaƟve leap in water safety monitoring worldwide.

Public health relevance
Narrative. Water pollution is a global crisis driven by hundreds of thousands of chemicals, many with unknown health risks. Existing testing methods often miss hidden dangers of complex contaminant mixtures. We propose a two-tier WASANET system that uses a high-throughput, cell-based approach to measure overall water bioactivity, then pinpoints the most harmful pollutants for targeted action. By partnering with water authorities in several states, we aim to provide a cost-effective, single-scale measure of water safety that better protects public health.